Assessment of the therapeutic potential of the anticancer agent Silmitasertib in the treatment of memory loss in Frontotemporal dementia

Project Summary
Frontotemporal dementia (FTD) is a rare form of dementia that affects thousands of patients in the US and for
which there is no cure. FTD usually manifests with changes in personality, behavior or mood, memory loss,
confusion, and difficulty with day-to-day tasks. This symptomatology arises from neurodegeneration in the
frontal and temporal lobes, which are areas of the brain that control personality, emotions, behavior, and some
forms of cognition. One of the most common forms of FTD in the US is caused by mutations in Tau (sporadic
and genetic) causing Tau intracellular accumulation and aggregation, synaptic dysfunction, neuronal death,
and severe memory loss. Currently there are no US Food and Drug Administration (FDA) approved therapies
for FTD, and there are no treatments that can stop or alter the course of disease progression. Therefore, there
is an unmet need for the development of therapeutic strategies that can improve the quality of life of patients
with FTD. We previously showed that the serine/threonine Protein kinase CK2 alpha prime (CK2α’) is a
pathological sensor activated in the presence of protein aggregation and synaptic dysfunction in different
human proteinopathies such as Huntington’s disease (HD) that contributes to neurodegeneration and
behavioral alterations. Our previous and preliminary data demonstrated that some forms of FTD present
similarities in the mechanisms that lead to neurodegeneration and behavioral deficits with HD. Our preliminary
data removing one allele of CK2α’ in the FTD PS19 mouse model expressing a Tau mutation (P301L)
associated with hereditary FTD restored the expression of glutamate related signaling (GRS) genes, increased
soluble Tau levels and rescued memory deficits assessed in the Barnes maze task. These results represent a
strong foundation for the pharmacological inhibition of CK2α’ as a potential therapeutic strategy for the
treatment of neurodegeneration and memory decline associated with FTD. In this proposal we will investigate
the therapeutic potential of the pharmacological inhibition of CK2α’ in the treatment of memory deficits
associated with FTD using the FDA approved CK2 inhibitor Silmitasertib (CX4945). CX4945 is currently in
clinical trials for the treatment of several cancers, is oral bioavailable and safe in humans, and if proven
efficacious in the amelioration of memory loss in FTD mice it could become a potential therapeutic strategy for
the treatment of FTD. We will treat two different groups of mice (pre-symptomatic and early symptomatic) and
will evaluate the impact of CX4945 in learning and memory by conducting three different behavioral tasks (Y
maze for spatial working memory, T-maze for spatial reference memory and Barnes maze for spatial learning
and memory). We will conduct RNA-seq analyses in the FC of mice to assess the impact of CX4945 on GRS
and other synaptic genes and its association with Tau/TauP levels and neuronal function using Ca2+ imaging
analyses. Successful completion of this study will consolidate the role of CK2α’ in FTD and will establish proof
of concept for the therapeutic potential of using CK2 inhibitors for the treatment of memory loss in FTD.

Public health relevance
Project Narrative Frontotemporal dementia (FTD) is a rare form of dementia associated with Alzheimer’s disease and related dementias (AD/ADRD) that affects thousands of individuals in the US and for which there is no cure. Drug discovery is extremely important to develop effective drugs for the treatment of FTD and other neurodegenerative diseases, but it is a highly costly and time-consuming process. An alternative strategy is the re-purpose of FDA approved drugs to expedite the development of therapeutic strategies to treat memory loss and improve the quality of life of patients with FTD.